Colorado HNC SPORE Career Enhancement Program

SUMMARY, Career Enhancement Program
The goal of the Career Enhancement Program (CEP) is to promote and support promising candidates at the
University of Colorado Cancer Center (UCCC) who are interested in pursuing a career as translational
researchers in head and neck cancer (HNC). The program will encourage applicants from a variety of disciplines
to undertake studies under the guidance and support of the Colorado HNC SPORE. The program will evaluate
the most promising investigators based on their training and specific projects proposed. Our SPORE will support
awardees for their research career developmental activities through SPORE funding and institutional matching
funds designated to the CEP. Once awardees are selected, investigators from the Colorado HNC SPORE and
other investigators in the UCCC will act as mentors to advise and evaluate them as they initiate and pursue their
research projects. Productivity will be evaluated not only by numbers of publications and grants, but also by the
establishment of new collaborations and networking within the institution, and with other SPORE investigators
across the country. Powerful mentoring tools including workshops in training mentors and interactions of mentor-mentee pairs will assure awardees’ success. Outstanding CEP projects may be promoted to full projects within
the Colorado HNC SPORE to replace those that are not meeting their translational research objectives or that
have been completed. Successful CEP awardees may be provided with continued support as project co-leaders
of the promoted projects. Funding for this CEP will help these individuals succeed as they pursue academic
research careers and will provide new ideas and approaches to the overall Colorado HNC SPORE.

Public health relevance
NARRATIVE, Career Enhancement Program The Career Enhancement Program (CEP) will encourage promising candidates at the University of Colorado Cancer Center to pursue translational research careers in head and neck cancer (HNC). The CEP will provide these investigators with financial support, mentorship for scientific projects and career development, and opportunities for collaboration. The long-term goal is to foster these individuals into successful independent research careers and to incorporate them and their new ideas/projects into the Colorado HNC SPORE.